DMS/NIGMS 2: Advanced Statistical Methods for Spatially Resolved Transcriptomics Studies

3URJUDP 'LUHFWRU 3ULQFLSDO ,QYHVWLJDWRU /DVW )LUVW 0LGGOH =KRX ;LDQJ 352-(&7 6800$5< 6HH LQVWUXFWLRQV 7KH UHFHQW HPHUJHQFH RI YDULRXV VSDWLDOO\ UHVROYHG WUDQVFULSWRPLF WHFKQRORJLHV KDYH HQDEOHG WKH VWXG\ RI VSDWLDO WUDQVFULSWRPLF ODQGVFDSH DFURVV D WLVVXH VHFWLRQ RU ZLWKLQ VLQJOH FHOOV FDWDO\]LQJ QHZ GLVFRYHULHV LQ PDQ\ DUHDV RI ELRORJ\ 'HVSLWH WKH IDVW GHYHORSPHQW RI VSDWLDO WUDQVFULSWRPLF WHFKQRORJLHV KRZHYHU VWDWLVWLFDO PHWKRGV IRU DQDO\]LQJ VSDWLDO WUDQVFULSWRPLF GDWD DUH YDVWO\ XQGHUGHYHORSHG $QDO\]LQJ VSDWLDO WUDQVFULSWRPLF GDWD IDFHV LPSRUWDQW VWDWLVWLFDO FKDOOHQJHV WKDW DULVH IURP WKH FRPSOH[LWLHV DQG XQLTXH IHDWXUHV RI WKHVH GDWD +HUH ZH SURSRVH WR DGGUHVV VRPH RI WKHVH NH\ VWDWLVWLFDO FKDOOHQJHV LQ WKLV HPHUJLQJ ILHOG WKURXJK GHYHORSLQJ D VXLWH RI QRYHO VWDWLVWLFDO PHWKRGV 6SHFLILFDOO\ ZH ZLOO GHYHORS *DXVVLDQ SUHGLFWLYH SURFHVV PRGHOV WR PRGHO WKH VSDWLDO FRUUHODWLRQ VWUXFWXUH LQ D FRPSXWDWLRQDO HIIHFWLYH ZD\ WR UDSLGO\ LGHQWLI\ JHQHV ZLWK VSDWLDO H[SUHVVLRQ SDWWHUQV GHYHORS LQWHJUDWLYH PHWKRGV WR LQFRUSRUDWH UHIHUHQFH VLQJOH FHOO 51$ VHTXHQFLQJ GDWD DORQJ ZLWK VSDWLDO FRUUHODWLRQ VWUXFWXUH LQ VSDWLDO WUDQVFULSWRPLFV WR HQDEOH DFFXUDWH GHFRQYROXWLRQ RI FHOO W\SHV RQ WKH WLVVXH GHYHORS 3RWWV PRGHOV WR SHUIRUP WLVVXH VHJPHQWDWLRQ DQG GHWHFW WLVVXH UHJLRQV DQG PLFURHQYLURQPHQW LQ D GH QRYR IDVKLRQ :H ZLOO GHYHORS GLVWULEXWH DQG VXSSRUW XVHU IULHQGO\ RSHQ VRXUFH VRIWZDUH LPSOHPHQWLQJ WKH SURSRVHG PHWKRGV DQG GLVVHPLQDWH WKHP WR WKH VFLHQWLILF FRPPXQLW\ :H ZLOO SHUIRUP ULJRURXV DQG FRPSUHKHQVLYH VLPXODWLRQV DQG DSSO\ RXU PHWKRGV WR DQDO\]H PXOWLSOH SXEOLF VSDWLDO WUDQVFULSWRPLFV GDWD WKDW DUH FROOHFWHG IURP GLIIHUHQW WHFKQLFDO SODWIRUPV DQG DUH RI GLIIHUHQW VFDOHV :H ZLOO DOVR SHUIRUP DQ LQ GHSWK DQDO\VLV ZLWK VXSSOHPHQWDO H[SHULPHQWV RQ WKH VSDWLDO WUDQVFULSWRPLFV GDWD EHLQJ FROOHFWHG DV SDUW RI WKH VWXG\ RI WKH UROH RI G\VUHJXODWHG VWHP FHOO ELRORJ\ LQ EUHDVW FDQFHU GLVSDULWLHV LQ $IULFDQ $PHULFDQ ZRPHQ 5(/(9$1&( 6HH LQVWUXFWLRQV :H SURSRVH WR GHYHORS D FRPSUHKHQVLYH VHW RI VWDWLVWLFDO PHWKRGV IRU DQDO\]LQJ GDWD FROOHFWHG IURP VSDWLDOO\ UHVROYHG WUDQVFULSWRPLFV VWXGLHV WR DGYDQFH ELRORJLFDO GLVFRYHULHV 7KHVH VWDWLVWLFDO PHWKRGV ZLOO KHOS XV EHWWHU XQGHUVWDQG WKH VSDWLDO WUDQVFULSWRPLF ODQGVFDSH DQG FHOO W\SH FRPSRVLWLRQ RI FRPSOH[ WLVVXHV DV ZHOO DV WKH IXQFWLRQDO DQG VWUXFWXUDO IRXQGDWLRQV RI WLVVXH DUFKLWHFWXUH WKXV IDFLOLWDWLQJ WKH LQYHVWLJDWLRQ RI GLVHDVH HWLRORJ\ DQG WKH GHYHORSPHQW RI SUHFLVLRQ PHGLFLQH 352-(&7 3(5)250$1&( 6,7( 6 LI DGGLWLRQDO VSDFH LV QHHGHG XVH 3URMHFW 3HUIRUPDQFH 6LWH )RUPDW 3DJH 3URMHFW 3HUIRUPDQFH 6LWH 3ULPDU\ /RFDWLRQ 2UJDQL]DWLRQDO 1DPH 5HJHQWV RI WKH 8QLYHUVLW\ RI 0LFKLJDQ '816 6WUHHW 6RXWK 6WDWH 6W I6WUHHW &LW\ $QQ $UERU I&RXQW\ :DVKWHQDZ I6WDWH 0, 3URYLQFH I&RXQWU\ 86$ I=LS 3RVWDO &RGH 3URMHFW 3HUIRUPDQFH 6LWH &RQJUHVVLRQDO 'LVWULFWV 0, $GGLWLRQDO 3URMHFW 3HUIRUPDQFH 6LWH /RFDWLRQ 2UJDQL]DWLRQDO 1DPH '816 6WUHHW I6WUHHW &LW\ I&RXQW\ I6WDWH 3URYLQFH I&RXQWU\ I=LS 3RVWDO &RGH 3URMHFW 3HUIRUPDQFH 6LWH &RQJUHVVLRQDO 'LVWULFWV 3+6 5HY $SSURYHG 7KURXJK 20% 1R 3DJH )RUP 3DJH 3URJUDP 'LUHFWRU 3ULQFLSDO ,QYHVWLJDWRU /DVW )LUVW 0LGGOH =KRX ;LDQJ 6(1,25 .(< 3(56211(/ 6HH LQVWUXFWLRQV 8VH FRQWLQXDWLRQ SDJHV DV QHHGHG WR SURYLGH WKH UHTXLUHG LQIRUPDWLRQ LQ WKH IRUPDW VKRZQ EHORZ 6WDUW ZLWK 3URJUDP 'LUHFWRU V 3ULQFLSDO ,QYHVWLJDWRU V /LVW DOO RWKHU VHQLRU NH\ SHUVRQQHO LQ DOSKDEHWLFDO RUGHU ODVW QDPH ILUVW 1DPH H5$ &RPPRQV 8VHU 1DPH 2UJDQL]DWLRQ 5ROH RQ 3URMHFW =KRX ;LDQJ ;,$1*=+28 8QLYHUVLW\ RI 0LFKLJDQ 3' 3, &RODFLQR -XVWLQ &2/$&,12 8QLYHUVLW\ RI 0LFKLJDQ &R ,QYHVWLJDWRU 6H[WRQ -RQDWKDQ -B6(;721 8QLYHUVLW\ RI 0LFKLJDQ &R ,QYHVWLJDWRU 27+(5 6,*1,),&$17 &2175,%87256 1DPH 2UJDQL]DWLRQ 5ROH RQ 3URMHFW +XPDQ (PEU\RQLF 6WHP &HOOV 1R ? <HV ,I WKH SURSRVHG SURMHFW LQYROYHV KXPDQ HPEU\RQLF VWHP FHOOV OLVW EHORZ WKH UHJLVWUDWLRQ QXPEHU RI WKH VSHFLILF FHOO OLQH V IURP WKH IROORZLQJ OLVW KWWSV JUDQWV QLK JRY VWHPBFHOOV UHJLVWU\ FXUUHQW KWP 8VH FRQWLQXDWLRQ SDJHV DV QHHGHG ,I D VSHFLILF OLQH FDQQRW EH UHIHUHQFHG DW WKLV WLPH LQFOXGH D VWDWHPHQW WKDW RQH IURP WKH 5HJLVWU\ ZLOO EH XVHG &HOO /LQH 3+6 5HY $SSURYHG 7KURXJK 20% 1R 3DJH )RUP 3DJH FRQWLQXHG 1XPEHU WKH IROORZLQJ SDJHV FRQVHFXWLYHO\ WKURXJKRXW WKH DSSOLFDWLRQ 'R QRW XVH VXIIL[HV VXFK DV D E

Public health relevance
RELEVANCE We propose to develop a comprehensive set of statistical methods for analyzing data collected from spatially resolved transcriptomics studies to advance biological discoveries. These statistical methods will help us better understand the spatial transcriptomic landscape and cell type composition of complex tissues as well as the functional and structural foundations of tissue architecture, thus facilitating the investigation of disease etiology and the development of precision medicine